Non Invasive Assessment of Microcirculation Function and Kidney Disease

PROJECT SUMMARY
This is a submission of a K23 application by Dr. Rakesh Malhotra, MD, MPH, a nephrologist at
University of California San Diego (UCSD). Through this proposal Dr. Malhotra intends to establish himself as
an independent investigator studying non-invasive microvascular measurements in chronic kidney disease
(CKD).
Candidate: Dr. Malhotra’s training objectives include; 1) to become proficient in the measurement of non-
invasive microvascular techniques and translation to patient-oriented research; 2) to gain expertise in
advanced statistical methods relevant to clinical trials; and 3) to learn the necessary skills to develop an
independent research program and to design and lead clinical trials. Dr. Malhotra will accomplish these
objectives through mentorship, coursework, and participation in workshops. He has assembled a
multidisciplinary team of scientists including Dr. Joachim Ix, an expert clinical trialist (primary mentor), Dr. Boy
Houben, a leader in the field of microcirculation (co-mentor); Dr. Matthew Allison, a leader in the field of
vascular health and assessment (co-mentor) and Dr. Florin Vaida, a PhD level biostatistician (statistical co-
mentor). In addition, Dr. Haiyan Zhang a renal pathologist with experience in nephropathology and Dr. Ithaar
Derweesh a urologist with expertise in minimally invasive surgery will participate as a consultant without pay.
Research: Renal microcirculation plays an important role in the pathogenesis of CKD. The kidney biopsy is
the standard technique to assess abnormalities in renal microvasculature, but is invasive and rarely done. Dr.
Malhotra’s overall hypothesis is that the non-invasive microvascular measurements may improve our
understanding of the renal microcirculation, and improve our ability to identify those at risk of kidney disease
progression. In Aim 1, Dr. Malhotra will evaluate the relationship between non-invasive microvascular
measurements (skin capillary density and % recruitment (by capillaroscopy) and heat-induced skin %-
hyperemia (by laser Doppler)) with glomerular sclerosis among 100 individuals with CKD undergoing kidney
biopsy and 50 persons with CKD undergoing nephrectomy for suspected kidney cancer. In Aim 2a, Dr.
Malhotra will evaluate the association of clinical risk factors with microvascular dysfunction as assessed with
capillaroscopy and laser Doppler among 200 CKD subjects. In Aim 2b, Dr. Malhotra will determine the
associations between skin microvascular function and longitudinal changes in kidney function in the 200 CKD
subjects. Lastly, in Aim 3, Dr. Malhotra will evaluate whether acute changes in % capillary recruitment in
response to a dietary protein load is correlated with concurrent changes in eGFR, as measure of RFR in 20
CKD subjects. Both the training and research plans will lay the groundwork for use of non-invasive
microvascular techniques in clinical trials to allow assessment of renal hemodynamics and monitor responses
to therapies and clinical outcomes in the next and independent phase of Dr. Malhotra’s career.

Public health relevance
PROJECT NARRATIVE Microvascular dysfunction is a central pathogenic feature of chronic kidney disease, but routine assessment of renal microcirculation is difficult without a kidney biopsy. Whether non-invasive measurement of microvascular abnormalities can identify persons at risk for future loss of kidney function is unknown. The objectives of this proposal are to 1) understand how microvascular measurements are related to kidney histology, 2) investigate clinical determinants of microvascular dysfunction in kidney disease patients, 3) determine whether microvascular dysfunction is associated with kidney disease progression over time and 4) evaluate whether non-invasive microvascular measurements can determine renal function reserve.